Role of claudin-2 in Calcium Homeostasis and Kidney Stone Disease

PROJECT SUMMARY/ABSTRACT
Kidney stones affect 9% of the population and idiopathic hypercalciuria is the major pathogenic risk factor. Our
long-term goal is to elucidate the pathogenesis of idiopathic hypercalciuria and develop novel therapies. The
renal proximal tubule reabsorbs 70% of filtered calcium, which is believed to occur via the paracellular pathway.
Claudin-2 is a paracellular cation channel that is expressed in the proximal renal tubule and in intestinal
epithelium. In preliminary studies, we show that claudin-2 knockout mice have renal and absorptive
hypercalciuria, leading to severe papillary nephrocalcinosis. Moreover, we find that claudin-2 gene variants are
associated with kidney stone disease in humans. We hypothesize that claudin-2 mediates calcium reabsorption
in the proximal tubule and calcium secretion in the colon. Loss of claudin-2 increases calcium delivery to the
loop of Henle, and predisposes to inner medullary calcium deposition and hence kidney stone disease. The
specific aims to test this hypothesis are: (1) Test whether claudin-2 mediates paracellular calcium reabsorption
in the renal proximal tubule. We will use tubule micropuncture of claudin-2 global knockout mice, determine the
contribution of the proximal tubule with kidney-specific conditional knockout mice, test the role of claudin-2 in the
hypocalciuric effect of thiazides, and explore the effect of sex. (2) Test whether claudin-2 mediates intestinal
secretion of calcium. We will generate intestine-specific claudin-2 knockout mice and perform tracer flux assays
in everted intestinal sacs and Ussing chamber preparations. (3) Test whether human claudin-2 gene variants
and protein expression are associated with urine calcium and kidney stones. We will conduct a gene association
study in 3 U.S. population-based cohorts to test the association of claudin-2 gene polymorphisms with a history
of kidney stones and calcium excretion. In a separate cohort of kidney stone formers and matched normal
volunteers, we will test the association of claudin-2 protein abundance in urinary exosomes with hypercalciuric
kidney stone disease.

Public health relevance
NARRATIVE This project seeks to understand the mechanism and role of claudins, which are proteins found at the cell junction in the proximal tubule of the kidney. This may lead to novel insights into how the kidney regulates calcium in the urine, what factors increase risk for kidney stones, and to the development of new treatments to reduce urine calcium and kidney stone frequency.